Supplement: Epigenetics of the Human Gut Microbiome

Project Summary
The proposed supplement will expand the original studies that address the role of bacterial epigenetics in the
human gut microbiome and their mechanistic links to health and disease. Virtually all microbes possess DNA
modifications – the epigenome -- inherited marks that regulate gene expression and function as immune
systems, most commonly in restriction-modification (RM). While well-characterized DNA methylation-based
RM systems are well established, there are now >30 DNA modifications defined in bacteria and bacteriophage,
including our recent discovery of phosphorothioate (PT) and 7-deazaguanine modifications. DNA modifications
also regulate gene expression to control heritable gene expression affecting virulence and bacteriophage
resistance, as well as non-heritable gene expression. While these examples of bacterial epigenetics have links
to human disease, we know little about how DNA modifications determine or affect microbial populations in the
gut, how they affect the behavior or survival of individual microbial species, or if there is a relationship between
specific microbiome epigenetics and human health and disease. Here we use innovative analytics, informatics,
and genomics tools to explore these questions, with a focus on a bacterial DNA modification found in ~15% of
human gut microbes: PT modifications, in which a redox-active S replaces a non-bonding oxygen in the DNA
backbone. These studies are driven by the widespread distribution of PTs in bacterial pathogens and
commensals, the susceptibility of PTs to oxidation by chemical mediators of inflammation, and the known
effects of inflammation on gut microbiota, all of which suggest that inflammation could alter the balance of PT-
containing gut microbes. However, we know virtually nothing about microbiome epigenetics, much less which
gut bacteria possess redox-sensitive PTs and other epigenetic marks. We now propose to define the
landscape of PT-containing bacteria in the healthy human gut, elucidate the role of PTs in microbiome changes
during gut inflammation, and discover new epigenetic marks in the gut microbiome. We start by quantifying
PTs and identifying PT-containing bacteria in fecal DNA samples from healthy donors to the Broad Microbiome
Library and in ~7000 strains cultured from these samples (dnd genes found in 15%). We then test the idea that
redox-sensitive PTs affect bacterial fitness in the inflamed gut, quantifying PT levels and PT-containing
bacteria in 20-30 fecal samples from inflammatory bowel disease (IBD) patients. Finally, we will identify new
DNA modifications in gut microbes, using novel technologies to discover DNA marks in banked fecal samples
from BML donors and strains, and then link them to unique microbiome phenotypes and associations with
human disease. The significance of this project lies in the potential role for PT-containing microbes in human
health and disease, the potential clinical impact of PT-containing bacteria on IBD, and the development of new
tools to discover new microbiome epigenetic systems.

Public health relevance
Narrative DNA modifications in epigenetic systems play critical roles in bacterial interactions with each other and with bacteriophage, yet little if anything is known about the role of epigenetics in human microbiome communities. Here we explore the epigenetic landscape of human gut microbes, starting with sulfur-containing, oxidation- sensitive phosphorothioate (PT) DNA modifications found to be abundant in the human gut microbiome and hypothesized to affect bacterial survival in inflammatory bowel disease. The tools developed to study PT epigenetics will then be used to discover and characterize entirely new DNA modifications in gut microbes, with the goal of linking microbial epigenetics with human health and disease.